Strengthening COVID-19 prevention strategies via wastewater surveillance in a Northern Plains Tribe

Despite the abundance of clinical and epidemiologic data collected during this pandemic, relatively
little focus has been paid to the examination of infectious agents through bulk wastewater detection and
epidemiological data that is particularly well-suited for disease surveillance in remote, frontier settings
such as the CRST Reservation.
The goal of this application is to develop and implement a 15-community wastewater testing
program for viral contaminants, including SARS-CoV-2, to better understand the utility of wastewater
testing and COVID-19 or other viral outbreaks in this remote, low-resourced, and relatively low-density
Tribal community.
We will use our highly collaborative, multidisciplinary team of Native investigators to develop and
implement, and evaluate the effectiveness of a viral wastewater sequencing testing program in a very
rural and remote Northern Plains Lakota Reservation.
Therefore, we propose to leverage our 20-year, long-running partnership with CRST to address the
following Specific Aims:
1. Use a highly participatory approach to design, garner approval for, and implement a wastewater
testing system in a large Tribal reservation community. This community surveillance approach will
screen for viral isolates, including SARS-CoV-2, in coordination with CRST’s preexisting COVID-19
surveillance system; and
2. Deploy qualitative methods to examine 16 key Tribal stakeholders’ and Tribal members’
attitudes towards this new community wastewater testing approach and, ultimately, how this
new environmental testing effort affects Tribal members socially, ethically, and behaviorally; and
3. Seek to codify this new resource into the Tribe’s public health emergency response program,
thereby enhancing the Tribe’s capacity for future viral and other likely epidemic and pandemic
outbreaks.

Public health relevance
The implementation of a 15-community wastewater treatment testing program on the CRST Reservation will increase the Tribe’s surveillance capacity in very important ways, such as the introduction, trajectory, and origin of new infectious disease cases, including SARS-CoV-2. This project will also help to inform knowledge gaps regarding virus subtypes within this Tribal community, and whether this type of testing can be feasibly implemented in relatively low-density settings.